AL-ALI (UNIVERSITY OF MIAMI, SCHOOL OF MEDICINE) - MCSP - EXPLORATORY CHEMISTRY (EC)

The Contractor, in performance of work under this task order, shall
provide a full-service facility and staff who would support a medicinal chemistry discovery
program beginning at the Exploratory Chemistry phase to develop structure activity
relationship (SAR) analysis and design, synthesis, in vitro absorption, distribution, metabolism,
excretion and toxicology (ADMET), computational chemistry/Computer Aided Drug Discovery
(CADD) and compound logistics of storage and shipping to support the Contributor Dr. Al-Ali
(University of Miami, School of Medicine (SOM)) in developing a novel therapeutic to treat
spinal cord injury. This will be achieved by advancing the SAR/SPR of their small molecule
heterocyclic starting compound utilizing their assays and in vitro ADMET to identify novel,
selective compounds for the target enzymes that are directed at Alzheimer’s Disease. The
scope of this Medicinal Chemistry Support Program for Therapeutic Development (MCSP) task
order shall be under Performance Area 2: Medicinal Chemistry Support in support of preclinical
drug discovery efforts supported by NIH, NINDS and its Contributors, as per the Parent
Contract Statement of work (SOW).

Public health relevance
Development of therapy for spinal cord injury